Establishing a Gram-Negative Permeation Rule Set Leveraging a Unique Small Molecule Library

ABSTRACT
It has been more than 30 years since the first descriptions of the relationship between molecular
properties of antibiotics and their ability to accumulate within gram-negative bacteria.1,2 Considerable progress
towards understanding the structure and function of porin channels mediating drug uptake and RND efflux pumps
involved in drug elimination has followed.3 Yet, despite these advances, concise knowledge of the rules that
define small molecule accumulation within the gram-negative cell remains elusive. As such, the antibacterial
drug discovery process has reached an impasse. A solution to this discovery bottleneck is desperately needed
to effectively confront the threat posed by multidrug resistant gram-negative pathogens.4
Gram-negative bacteria are encapsulated by two membranes, with the asymmetric outer membrane
(OM) acting as a formidable permeability barrier to small molecules, including antibacterial drugs.5 Leaving aside
mechanisms of self-promoted uptake, hydrophilic antibiotics enter gram-negative cells largely through porin
channels that are believed to require increased drug polarity and low molecular weight to favor passage.6–9 Yet
some antibacterial drugs do not abide by these rule.10 Therefore, there must be some level of plasticity in these
rules that ultimately need to be learned and exploited.
Antibacterial drug discovery would greatly benefit from establishing concise rules for periplasmic
accumulation through improved outer membrane penetration. Despite exhaustive screening campaigns by drug
discovery companies, progress towards this goal has been limited by a number of important factors: i) few
chemical classes having measurable permeability in Gram-negatives from which to derive information, ii) minimal
chemical diversity among these chemical classes and iii) a general lack of broadly applicable, biologically-
relevant assays to measure small molecule accumulation in MDR gram-negative pathogens.
This proposal outlines a multifaceted approach to investigate determinants of small molecule permeation
in gram-negative bacteria from a unique compound collection assembled at VenatoRx Pharmaceuticals as part
of drug discovery programs for β-lactamase inhibitors, Penicillin Binding Proteins. Outer membrane
permeability-enabling parameters will be derived from this small molecule training set, analyzed by QSAR and
Principle Component Analysis to formulate rules to guide efforts to improve periplasmic accumulation in these
important pathogens. The established rule set for outer membrane penetration will be validated through direct
application to an active drug discovery program for Penicillin Binding Proteins focused on Enterobacteriaceae
and aiming to expand the spectrum through improved accumulation in P. aeruginosa and A. baumannii. Finally,
the proposed work will focus on demystifying outer membrane permeability to relieve the bottleneck of small
molecule impermeability in gram negatives and allow the rationale design of new gram-negative-biased chemical
libraries to significantly improve the success rates of translating molecular screening hits into therapeutically
active antibiotics.

Public health relevance
PROJECT NARRATIVE The general lack of permeability of small molecules and our inability to rationally improve intracellular accumulation of target-based screening hits in gram-negative bacteria is the most challenging bottleneck to antibacterial drug discovery and the reason the pharmaceutical industry has failed to successfully introduce new antibacterial agents into clinical practice. To meaningfully confront the continually evolving challenge of multidrug resistance in gram-negative bacteria, a thorough understanding of the critical small molecule parameters and their optimal ranges for improved cellular accumulation must be learned to demystify this critical drug discovery bottleneck. VenatoRx Pharmaceuticals along with a talented team of academic scientists will tackle this problem by extracting critical permeability determinants from a unique collection of small molecules assembled from active drug discovery programs exhibiting significant physicochemical and structural diversity and varying degrees of permeability in gram-negative bacteria. The goal of the study is to expand our understanding of critical molecular parameter limits for outer membrane penetration and periplasmic accumulation of small molecules in clinically important multidrug resistant pathogens (e.g., carbapenem-resistant Enterobacteriaceae, P. aeruginosa and A. baumannii). Publishing these important findings will facilitate the future identification of overlapping properties to those required for cytoplasmic membrane penetration and help in creating a gram-negative permeation rule set for these important pathogens.